Development of Epitope-Targeted SARS-CoV-2 Vaccines

A vaccine against SARS-CoV2 is badly needed. We have developed a vaccine platform technology based on virus-like particles (VLPs) of RNA phages like MS2, PP7, AP205 and Qß. When displayed multivalently on these bionanoparticles, peptide and protein antigens acquire a high level of immunogenicity. They elicit high titer and long-lived antibody responses to virtually any displayed antigen. Moreover, the VLP platform has rapid response potential to quickly counter emerging threats. Here we describe an approach to the display of SARS-CoV2 epitopes, and tests of their ability to elicit neutralizing and protective antibodies in mice. Our approach consists of three specific aims: In Aim 1, we will Identify candidate vaccine epitopes for SARS-CoV2 and endow them with high immunogenicity by displaying them on VLPs. This virus shares sufficient sequence and structural homology with SARS-CoV1 to allow us to infer likely neutralizing epitopes from knowledge of the targets of its neutralizing antibodies. Accordingly, we describe strategies for display and optimization of spike protein epitopes we predict will elicit antibodies that will separately inhibit two essential steps in virus entry - receptor binding and virus-cell fusion. In Aim 2, we will immunize mice with candidate VLPs and will use ELISA to quantify the resulting antibody responses, testing the reaction of sera with recombinant spike protein and with synthetic peptides representing the chosen epitopes. In Aim 3, the neutralization activity of sera will be tested by plaque reduction neutralization tests in cultured cells. Subsequently, we will vaccinate mice transgenic for human ACE2 (the SARS-CoV2 receptor) and test their abilities to resist the effects of SARS-CoV2 infection.

Public health relevance
OVERALL COMPONENT: THE UNIVERSITY OF NEW MEXICO CANCER CENTER PROJECT NARRATIVE Designated as one of the nation's National Cancer Institute Cancer Centers since 2005, the University of New Mexico Cancer Center is a cancer treatment, research, and education and training center that applies the scientific expertise of its investigators to those cancers that have high incidence, mortality, or disparity in the multiethnic and underserved populations of New Mexico. The Center is a hub for promoting discovery through its research, education and training, clinical care, statewide outreach programs and networks for community participatory research. The Center connects scientists, healthcare professionals, and communities to translate its discoveries to cancer clinical trials, and cancer control and behavioral interventions that reduce the cancer burden of New Mexico and serve as a national model. The goal of the Center is to assure that all of the people in New Mexico, its catchment area, have access to high quality cancer care and collaborate in and benefit from advances in cancer research.